Girasoles 2.0: Understanding the Role of Microbiota, Inflammation, and Metabolomics in Heat-related Illness

With climate models projecting increasing frequency and severity of heat waves, heat-related illness (HRI) due
to environmental exposure is a public health concern. HRI covers a spectrum of symptoms, ranging in severity
from sweating to heat stroke or, perhaps, death. Despite recent advances, HRI pathophysiology is not well
understood. Heat initiates HRI, but septicemia becomes a driving factor after adaptive mechanisms fail.
Evidence suggests gut microbiota and inflammation drive escalating heat stress response into florid HRI. Gut
microbes and the short chain fatty acids (SCFAs) they produce modulate immune function. Inflammatory
biomarkers and measurable plasma lipopolysaccharide (LPS) levels, a bacterial cell wall constituent that, when
measured in blood, provides evidence of bacterial translocation from gut, indicate gut permeability increases in
HRI. Primary and secondary bile acids (PSBAs) may shape and be shaped by gut microbes. We will assess the
role of gut microbiota and their interplay with inflammation and metabolism to further explore HRI
pathophysiology. Our overarching hypothesis is gut microbial communities, systemic and gut
inflammation, SCFAs, and PSBAs influence the likelihood and severity of HRI, which we will
evaluate in a cross-sectional study of 100 agricultural workers who labor in extreme heat environments. Our
project translates from 1) the infrastructure resulting from our experience since 2009 collaborating with the
Farmworker Association of Florida in prior and current investigations of health issues among Hispanic
agricultural workers exposed to high heat environments; and 2) exciting preliminary data demonstrating
microbial community changes associated with high heat exposure and perturbations of metabolic pathways for
SCFAs among heat-exposed agricultural workers in relation to HRI. To complement our expertise in HRI and
inflammation, we are fostering new collaborations with Dr. Ortlund (Emory University; lipidomics) and Dr.
Konstantinidis (Georgia Institute of Technology or “Georgia Tech”; microbiome). We will execute the following
specific aims: 1) using whole genome sequencing, evaluate gut microbial species or strain genomes correlating
with symptoms and perform targeted isolation of the most promising strains to validate their functional role
using human cell lines under high vs. normal body temperatures; 2) evaluate plasma and stool inflammatory
biomarkers in relation to symptoms; and 3) evaluate SCFA and PSBA concentrations in plasma and stool. We
will perform integrative analyses to improve understanding of interrelationships between gut microbial
communities, inflammation, and metabolism. For metabolites associated with microbial species or strains, we
will perform functional gene annotation and flux balance metabolic modeling of corresponding genomes to
further corroborate the associations, creating hypothesis about which metabolite is produced by which microbial
species and testing them experimentally. Our results will allow discernment of novel biomarkers of HRI
vulnerability, spurring new preventive approaches or treatments in the setting of extreme heat environments.

Public health relevance
PUBLIC HEALTH RELEVANCE This transdisciplinary project proposes a new, high impact virtual consortium to conduct synergistic and translational research to elevate our knowledge of the biological processes underlying heat-related illness due to occupational heat exposure. We will explore the interrelationships between exertional and environmental heat stress, gut microbial communities, systemic inflammation, short chain fatty acids, bile salts, and the likelihood and severity of heat-related illness in 100 Florida agricultural workers who labor in heat-intensive environments. Our work will transform our understanding of heat-related illness physiology by identifying biomarkers of heat-related illness vulnerability and spurring new preventive approaches or heat-related illness treatments in the setting on extreme heat environments.